GENETIC ANOMALIES OF C4, CR1, AND FCR IN JUVENILE IGA-NEPHRITIS

This study tests the hypothesis that: 1) abnormalities in complement and/or FcR mechanisms for processing and clearing circulating immune complexes (IC) are often present in IgA Nephritis (IgA-N), and 2) the extent of these abnormalities can determine whether the patient will experience juvenile or adult-onset IgA-N.